Understanding the influence of Mitochondrial DNA haplotypes on breast aging and cancer

The rate of aging of the breast differs between women. Further, older women tend to develop estrogen
receptor alpha (ERα) positive breast cancer sub-type, despite lower hormonal levels. Our preliminary data
compel us to hypothesize that mitochondrial genetics alters the rate of aging of the breast and impacts the sub-
type of breast cancer. The mammary ductal tree is composed of luminal hormone sensitive (HS), ERα positive
cells as well as luminal alveolar (AV) and basal cells that are both ERα negative. A recent scRNAseq analysis
revealed that in both the basal and luminal AV cells, mitochondrial function declines with age but this decline
was not observed in luminal HS cells. Rather, the luminal HS cells seem to up-regulate of the unfolded protein
response of the endoplasmic reticulum (UPRER). The UPRER is closely interconnected with the mitochondrial
UPR (UPRmt). Our group has identified the ERα and the mitochondrial sirtuin-3 (SIRT3) as key players of the
UPRmt. While the level of the ERα does not fluctuate with age, in most individuals, SIRT3 levels decrease with
age. Therefore, our central hypothesis is that the decline in mitochondrial function observed in the basal and
luminal AV cells over aging may be due to the decline in the SIRT3 axis of the UPRmt. However, in the luminal
HS cells this decline is not observed as they maintain mitochondrial function through the ERα axis of the
UPRmt. We hypothesize that the ability of luminal HS cells to maintain mitochondrial function through aging,
allow them to survive transformation and explains the selective bias toward ERα positive breast cancer in older
women. Further, we performed RNAseq on the young and old-females derived mammary tumors and
established luminal HS cells derived from both young and aged females. We found that markers of the ERα
axis of the UPRmt and UPRER are up-regulated specifically in the aged luminal HS cells. This observation
suggests that the transcriptional program of the ERα may be altered by aging. We hypothesize that the
increase in ROS and the decline in hormones during aging alter the transcriptional program of the ERα.
Further, the rate of decline in SIRT3 with age varies between individuals. Likewise, we found that the levels of
SIRT3 differ between the BL/6NZB and BL/6C57 mice which have the same nuclear genome (BL/6), but different
mtDNA; (C57 or NZB). Therefore, the implication is that the rate of decline of the SIRT3 axis of the UPRmt with
age differs based on mtDNA haplotypes. Lastly, we hypothesize that while BL/6C57 mice (low SIRT3) will
develop exclusively ERα positive mammary tumor over aging, in BL/6NZB females (high SIRT3) both basal and
ERα positive mammary tumors will be observed. To test these hypotheses, we propose the following aims:
Specific aim 1: Analyze of the UPRmt and UPRER and the ERα transcriptome in ERα positive luminal mammary
cells over aging. Specific aim 2: Perform scRNAseq analysis of the mammary gland over aging in BL/6C57
and BL/6NZB mice. Specific aim 3: Compare the sub-types of mammary tumors between BL/6C57 and BL/6NZB
mice over aging. We propose to do these analyses in pre-, peri- and post-menopausal as well as elderly mice.

Public health relevance
The rate of aging of the breast shows high level of variability between women. This application focuses on the role of mitochondrial genetics in the regulation of the rate of aging of the breast and the increase susceptibility of aged breast to develop estrogen receptor alpha positive breast cancer.